Follicle-Inherent Biomechanical Mechanisms Underlying Ovulation

PROJECT SUMMARY
Ovulation is essential for human fertility. During ovulation, a fluid filled antral cavity that forms late in
folliculogenesis expands and, in coordination with thinning of a distinct region of the follicle wall, leads to rupture
and release of the cumulus oocyte complex. Impaired ovulation resulting from endocrinopathies, ovarian
pathologies, idiopathic anovulation, or ovarian aging are associated with decreased fertility. Improving our
understanding of ovulation biology will contribute to the development of novel treatment strategies for infertility,
as well as development of new non-hormonal contraceptives that block follicle rupture during ovulation. Although
previous research has elucidated many of the molecular mechanisms that underlie ovulation, less attention has
been paid to the role of biomechanical forces within the ovarian follicle in driving follicle rupture. Prior research
has characterized an increase in pressure in the region of the ovulatory follicle within the ovary; however, this
work was unable to distinguish the role of follicle-intrinsic forces from the external forces from the surrounding
ovarian microenvironment. Our lab and others have demonstrated formation of the antrum in an ex vivo model
of folliculogenesis and ovulation, suggesting that follicle-intrinsic forces drive fluid flow and cavity expansion in
the ovulatory follicle. Therefore, we will apply our ex vivo model of ovulation to study the follicle-intrinsic
biomechanical forces that drive ovulation, a promising strategy to integrate new technologies into the study of
ovulation and address unanswered questions about the role that pressure, wall tension, and fluid accumulation
plays in ovulation. Our overarching hypothesis is that increased intrafollicular pressure exerts
disproportionate wall tension on the rupturing side of the follicle due to localized wall thinning and that
the intrafollicular pressure increase is driven in part by downregulation of TRPV4 leading to reduced
calcium efflux and increased fluid influx into the antrum. We will quantify intrafollicular pressure and regional
wall tension within ovulatory follicles to determine if excess wall tension in one region of the follicle is predictive
of the site of rupture. We will also examine the role of TRPV4 as a novel regulator of antral cavity expansion and
subsequent ovulation efficacy. The long-term goal of the proposed work is to elucidate fundamental aspects of
ovulation biology and to pioneer the use of novel technologies that can quantify biomechanical parameters of
follicle rupture to study conditions of anovulatory infertility and to develop novel non-hormonal contraceptive
agents, all of which align directly with my own long-term career goals. Ultimately, the translational nature of this
project, the rich intellectual infrastructure of the Northwestern Center for Reproductive Science, and my
interdisciplinary mentoring team spanning disciplines of biomechanics, mathematics, bioinformatics, and
reproductive science and medicine will provide me with support and unprecedented skill sets to develop into an
independent clinician-scientist.

Public health relevance
PROJECT NARRATIVE The proposed studies will provide novel insight into the biomechanical forces and regulatory processes that drive ovulation while simultaneously providing me with scientific and leadership skills to be a successful clinician- scientist. I propose that during ovulation, progesterone decreases expression of a calcium channel, TRPV4, which promotes fluid accumulation in the ovarian follicle and leads to a disproportionate increase in pressure on the region of the follicle wall that will rupture to release the cumulus oocyte complex. Quantifying the biomechanical forces and regulators that drive follicle rupture during ovulation will lead to improved understanding of anovulatory infertility and to the development of novel non-hormonal contraceptives.